The CHARGE Study Phase II: A Multifactorial Approach to Autism Etiology

Abstract:
This project builds upon 15 years of the CHARGE Study, which identified numerous environmental chemicals,
nutritional factors, and maternal health conditions that are associated with altered risk for autism spectrum
disorder (ASD). This work provided clues about potential pathogenic mechanisms and also produced the first
evidence of gene-by-environment (GxE) interaction. In this renewal, CHARGE study will continue to enroll in
order to achieve a solid sample size for statistically powerful analyses of both chemical mixtures and GxE
interactions. Risk factors of concern are preeclampsia, air pollution, and pesticides, each having replicated
evidence of association with ASD. This application departs from the focus on single exposures in isolate, and
instead emphasizes multifactorial causation: the focus is on mixtures and interactions. In aim 1, state-of-the-art
methods will be applied to understand the impact of exposure mixtures on risk for ASD and if feasible, to
identify which component(s) of the mixture most contributes to the overall effects. Aims 2 and 3 address
interactions between genes and non-genetic factors (GxE). Aim 2 is to identify common gene variants carried
by the mother, which, in combination with early life environmental or medical factors, amplify the risk for ASD,
more so than when either factor is assessed separately. The Precision Medicine Array from the Affymetrix
platform will be used to generate over 800,000 SNPs that draw heavily from metabolic, pharmacologic, and
immune-related regions of the genome. This project then pre-selects subsets of genes biologically relevant to
the activity or mechanism of toxicity of each exposure, using annotated gene ontology databases. The
resulting GxE analyses are expected to identify common variants that act synergistically with environmental
insults, which may have been unremarkable in gene-only studies, or gene studies that emphasized rare
variants. Aim 3 examines GxE interactions as in Aim 2, for the child's gene variants. To our knowledge, this will
be the first study to evaluate GxE interaction utilizing omics-scale genetics data in a sufficiently powered
analysis for detecting interactions. The proposed work moves autism etiologic research into a new direction
that bridges separate silos of genetic and environmental research, creating a dynamic interdisciplinary and
integrative science. Given shared biologic pathways between some genes and certain environmental
exposures, the proposed project has potential to advance etiologic research towards targeted interventions
that could reduce risk for ASD or ASD-associated disabilities and improve lives of affected individuals and their
families. Additional significance may derive from identification of common variants that have hitherto eluded the
traditional genetics enterprise. The long-term impacts may therefore be the emergence of a shift in etiologic
research that unifies fragmented disciplinary approaches; major advancement in understanding common
variants; and the possibility for public health precision interventions that expand notions of genetic
susceptibility to encompass the biochemical milieu of the intrauterine and broader postnatal environment.

Public health relevance
Project Narrative This research project will investigate how environmental and genetic factors may interact in relation to a child’s risk for autism, which means that some children may be affected more than others by environmental chemicals, depending on their mother’s genetics or their own inherited genetics. This research has public health relevance because it can lead to finding ways to prevent autism, particularly for those with certain genes. If we can prevent at least some cases of autism, it will be a victory for children’s public health.